Optimizing Dual-Targeted and Dual-Armored CAR T Cells for Small Cell LungCancer

ABSTRACT
A patient's own T cells can be modified using gene therapy technology to express receptors, termed chimeric
antigen receptors or CARs, which allow these immune T cells to recognize proteins on the tumor cell surface,
and in turn allow these CAR modified T cells to recognize and kill the patient's own tumor cells. This approach
has been successful in some hematological malignancies, however, it has not been successful to date in solid
tumors including small cell lung cancer (SCLC). Two mechanisms by which SCLC may evade T cell-mediated
killing are loss of expression of antigens, and suppression of T cell function in the tumor microenvironment. In
this proposal, we will attempt to overcome these barriers by designing CAR T cells that target two SCLC antigens
simultaneously, and that produce multiple factors (“armors”) that enhance T cell activity in solid tumors. We
hypothesize that these dual-armored, dual targeted (DADT) CAR T cells will be more effective against SCLC
than previous T cell-mediated and immune therapies. We have previously shown that CAR T cells targeted to
either the antigen GD3 or to the antigen DLL3, both of which are expressed on the majority of small cell lung
cancers, are capable of killing SCLC cells in preclinical systems. Additionally, we have developed multiple
armored CAR T cells that secrete factors such as IL-18, or an antibody-derived single-chain variable fragment
(scFv) that blocks the immune checkpoint receptor PD-1, or an scFv blocking the phagocytosis-inhibitory signal
CD47 on tumor cells. All of these armors enhance CAR T cell activity in our in vivo model systems through
different mechanisms. In Aim 1 of this proposal, we will generate CAR T cells targeting DLL3 and GD3
simultaneously, to overcome antigen heterogeneity and antigen loss in tumors as a means of escape from T
cell-mediated killing. Simultaneously, in Aim 2, we will test pairs of armors to identify the pair that is the most
effective at enhancing the activity of single antigen-targeted CAR T cells against SCLC in vivo in
immunocompetent systems. We then analyze the immune cells in the SCLC tumor microenvironment following
CAR T cell treatment to assess changes mediated by the armored CAR T cells. Ultimately, in Aim 3, we will
combine these approaches to generate CAR T cells that recognize GD3 and DLL3 and produce multiple armors.
These DADT CAR T cells for SCLC may be suitable for further preclinical testing in preparation for clinical trials
beyond the scope of this proposal, representing a novel therapeutic approach to SCLC. Given our robust track
record in CAR T cell clinical translation, we fully anticipate having new CAR T cells suitable for clinical trials at
the conclusion of funding. Additionally, these novel CAR T cells may be used as tools to explore the interactions
between T cells and the SCLC microenvironment. The analysis of changes in SCLC tumors induced by the
armored CAR T cells proposed here may reveal novel aspects of SCLC biology and illuminate mechanisms of
immune escape and treatment failure in SCLC.

Public health relevance
NARRATIVE Most patients with relapsed small cell lung cancer (SCLC) have a very poor prognosis and the disease kills over 25,000 people annually in the US, highlighting the need for novel therapies to improve survival. A patient's own immune cells may be genetically engineered to recognize and kill tumor cells. This project is focused on using this technology to create patient T cells genetically engineered to optimally kill SCLC tumor cells and test this approach in preclinical models.